Molecular mechanisms underlying metabolic reprogramming by paternal benzene exposure

ABSTRACT
There is a major gap in our understanding of how paternal experiences leads to the increased risk of metabolic
disease in offspring. Here we focus on the heritable metabolic effects of benzene. Using a novel mouse model
for paternal benzene exposure, we provide convincing evidence for a causal relationship between paternal
benzene exposure and a sex specific offspring phenotype of impaired glycemic control when under metabolic
stress. We provide evidence for clear transcriptional signatures of metabolic disease, specifically in male
offspring. Based on these data we hypothesize that paternal benzene exposure triggers a specific signal in
sperm, which when transferred leads to predisposition to metabolic disease. To test the hypothesis, we will
utilize state of the art exposure system, a novel mouse model of intergenerational benzene exposure, and
pharmacological intervention to critically address the mechanism and pathophysiological significance
underlying metabolic programming triggered by benzene exposure. First we will perform in depth metabolic
and energy homeostasis phenotyping to identify the physiological consequences of paternal benzene exposure
in unexposed offspring. Second, we will identify the transcriptional signatures of intergenerational benzene
exposure in insulin sensitive tissues from offspring. Finally we will test if treatment of paternal metabolic
disease with a well characterized diabetes drug prevents the offspring phenotype; To define the mechanistic
basis for benzene-induced intergenerational reprograming, we will identify germline and epigenetic signatures
of benzene exposure, and mechanistically connect the epigenetic changes in the germline to offspring
transcriptional rewiring. The proposed research will, for the first time, define the causal relationship between
paternal exposure to benzene, and offspring metabolic disease susceptibility. Such a study will be of
importance to understand how paternal exposure drives non-genetic, metabolic reprogramming across
generations.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the predisposing factors for metabolic disease are largely unknown. Due to ethical and technical limitations of human studies the demonstration of causality is impossible and mechanistic insights remain inaccessible. The project will use a newly developed mouse model to study how paternal exposure to benzene, a major air pollutant, triggers an alternative offspring developmental trajectory in offspring leading to increased susceptibility to metabolic disease.